Center for Undiagnosed Diseases at Stanford

ABSTRACT
The Undiagnosed Diseases Network (UDN) has facilitated access for patients with undiagnosed diseases to
the nation's leading clinicians and scientists. The UDN has brought cutting edge tools for disease discovery
and diagnosis to thousands of individuals across the country. UDN has made substantial efforts to improve
sustainability through the expansion of clinical sites, refinement of methods, and integration with existing
practices. Stanford Medicine has a strong commitment to the continuation of the Center for Undiagnosed
Diseases at Stanford, and has successfully applied lessons learned through research activities to improve the
care for all patients with undiagnosed diseases. We propose a program of study that will continue to facilitate
timely, accurate diagnosis of patients with undiagnosed diseases; advance research into underlying
mechanisms of disease; and foster cooperation and collaboration within the UDN and encourage engagement
of non-UDN clinicians, scientists, policy-makers, and funders to ensure this national resource is sustained long
beyond the duration of this proposal. Through experience at the Stanford Clinical Site we have identified
specific interventions that are expected to be helpful in enabling individuals of historically underserved
backgrounds to participate in and benefit from the Network. Through this supplement we will deploy and
evaluate new strategies for remote consent and sample collection. We will additionally adopt methods to
accelerate the review of digital medical records through the use of natural language processing tools.

Public health relevance
NARRATIVE The Stanford Clinic site of the Undiagnosed Diseases Network has successfully evaluated and diagnosed a large cohort of individuals with conditions that have eluded clinical diagnosis. We have pioneered a range of innovations to enhance our capabilities including RNA sequencing, long read DNA sequencing, and machine learning tools. Planned work provides new opportunities to streamline and expand enrollment and deploy innovative approaches for remote sample collection to facilitate diverse multi-omic analyses to enable deeper evaluation of patients unable to travel to the study site.